Role of ALL-1 Fusion Proteins in microRNA Biogenesis

Use continuation pages as neededto provide the required information in the format shown below. Start with Program Director(s)/Principal Investigators). List all other senior/key personnel in alphabetical order, last name first. Name eRA Commons User Name Organization Role on